Therapeutic Targets in Acute Chest Syndrome

SUMMARY
This project is aimed at improving the health of individuals who have sickle cell disease (SCD) by defining a
potential pro-survival factor of acute chest syndrome (ACS), and exploring whether this factor can be developed
as a molecular therapeutic. ACS is the leading pulmonary complication and a common cause of premature death
in SCD. There is no specific treatment for ACS despite decades of intensive research, and so it continues to be
a major clinical problem in SCD, particularly, in Africa. We recently discovered that extracellular heme triggers
ACS in an inflammatory process involving toll-like receptor 4 signaling. A growing number of experimental,
clinical and genomics studies support this model of ACS pathogenesis in which extracellular heme triggers the
acute lung injury. In this new R01 project, we test the novel idea that children express supra-physiological levels
of heme oxygenase-1 (HO-1), the rate-limiting heme degradation enzyme. We posit that the high-level HO-1 in
children enhances their ability to clear excess heme from the blood circulation to improve their overall outcome
from ACS. In pilot studies, we found that replenishing HO-1 in the plasma of adult SCD mice improved ACS
survival. These prior research provide a strong rationale to understand how endogenous HO-1 production is
regulated in SCD, and to test whether a recombinant HO-1 will be efficacious in treating ACS in a preclinical
model. Thus, in Aim #1, we will quantify blood HO-1 expression in patients and transgenic mice with SCD, and
examine whether HO-1 expression in peripheral blood mononuclear cells is influenced by miR-494 expression
and methylation of a highly conserved CpG site in HMOX1 the HO-1 gene. We will over-express and knock-
down miR-494 in human peripheral blood mononuclear cells, and knock-out HO-1 activity in peripheral blood
mononuclear cells of transgenic SCD mice, to determine the direct effects of these genetic/epigenetic alterations
on HO-1 concentration in the plasma. We will perform whole genome next generation sequencing of SCD
children with extreme levels of blood HO-1 level to identify novel whole genome sequence (WGS) variants that
influence activity of this enzyme independent of age, miR-494 and HMOX1 methylation. In Aim #2, we will study
a large cohort of SCD patients in Ghana to assess for the first time whether baseline blood HO-1 level, miR-494
level, HMOX1 methylation and WGS variants influence ACS risk. In Aim #3, we will use functional genomics to
test the importance of HO-1 expression in blood cells in improving ACS survival, and test the efficacy of a novel
truncated recombinant HO-1 molecule to rescue transgenic SCD mice from ACS. Data from this project has the
potential to fundamentally change our understanding of how the body naturalizes the danger posed by circulating
heme on organ function. In addition, it may provide a mechanism to explain the markedly variable ACS outcome
in children and adults, with a tangible therapeutic strategy that can be implemented expeditiously using our novel
HO-1 biologic.

Public health relevance
NARRATIVE Sickle cell disease (SCD) is one of the most common genetic disorders in the world. It is characterized by many acute manifestations most notably the acute chest syndrome (ACS), a severe lung complication that causes premature death in SCD. Currently, there is no specific treatment for ACS, and so it continues to be a major clinical problem globally. We have identified a potential reason that might explain why children survive ACS 10-times better than adults. This project will help us understand the protection in children, and to see if we can exploit it to develop a new and specific treatment for ACS for all patients.